Autism Spectrum Disorder in Rural Georgia: Education and Resources

PROJECT SUMMARY
Autism spectrum disorder (ASD) is a condition characterized by atypical social communication,
rigid thinking, and repetitive behavior that is becoming increasingly prevalent, with 1 in every
54 children meeting the diagnostic criteria. ASD signs and symptoms can vary broadly in their
presentation, from relatively mild impairments to symptoms severe enough that they prevent
individuals with ASD from living independently. Social support and early intervention therapies
however can significantly ameliorate the severity of several ASD symptoms. Notably, the
younger children are when therapies and interventions are begun, the more effective they will
ultimately be. While children can be reliably diagnosed with ASD at as young as 18 months, the
average age at time of diagnosis is 4.5 years which means that children with ASD often miss
therapeutic opportunities for lack of a diagnoses. Delayed diagnoses are especially common in
children from rural communities. Research that investigated possible causes for delayed ASD
diagnoses in rural communities found lack of parental knowledge about ASD, hesitancy among
clinicians to diagnose young children with ASD, and a lack of knowledge regarding steps to take
to have a child tested for ASD to be significant factors. In order to address ASD-related
disparities in rural communities, we created a webpage dedicated to helping families and
individuals effected by ASD navigate the diagnostic process. Our webpage directs users to ASD
“on-boarding’ organizations, and also has resources for finding early intervention therapy
centers near their home communities, provides links to financial resources, and links to
community based support organizations. We would like to expand our webpage into an online
ASD ToolKit that will be reviewed by rural families who have a child with ASD. Our ToolKit will
also give families opportunities to direct content creation by soliciting families’ input through
user feedback questions and focus groups. The goal of the ASD ToolKit is to create an easy to
use guide for living with and managing ASD in rural Georgia that has been shaped insights from
families affected by ASD. We will also create an online course about ASD diagnosis and
resources for rural physicians that will be informed by input from families affected by ASD. We
will invite feedback from our targeted physicians though user feedback questions and an ASD
resources quiz. Ultimately, we will use the physician input we receive on the course to develop
a continuing medical education (CME) program that will be available through Project ECHO.

Public health relevance
PROJECT NARRATIVE Autism spectrum disorder (ASD) frequently goes undetected in rural communities or is detected late, which can impair the ability of children with ASD to thrive both mentally and socially. Lack of awareness about ASD symptoms and resources among clinicians and community members in rural areas is a significant contributor to delayed diagnosis. Expanding our Autism Spectrum Resources in Georgia webpage into an online ASD ToolKit and developing an accompanying online course for Georgia healthcare workers will provide information and guidance on providing care for patients with ASD.